Combination nanovaccine-based immunization against influenza virus in the aged: immunity and protection

PROJECT SUMMARY / ABSTRACT
Age-related defects of the immune response contribute to reduced efficacy of the influenza vaccine in older
adults. Influenza A virus (IAV) infection results in greater risk of complications and higher hospitalization rates
in older adults, with approximately 90% of deaths occurring in adults over age 65. Therefore, the development
of a safe and effective vaccine that promotes protective immunity for the aged is an urgent public health need.
The overall goal of this revised R01 application is to identify the effect of vaccine biomaterials and adjuvants on
DC metabolism, and subsequent effects on antibody and T cell memory to develop a nanovaccine to overcome
age-related immune impairments. Vaccines for older adults can be further optimized with biomaterials that
enhance multiple arms of the immune system and provide a platform to expand antigen selection, broadening
protection. Our studies will establish the contribution of specific biomaterials and adjuvants in improving B and
T cell outcomes resulting in protection by enhancing vaccine efficacy. The goals are to: 1) develop an
efficacious influenza nanovaccine for older populations; and 2) to understand the mechanisms by which
rational selection of biomaterials and co-adjuvants in vaccines can enhance immune capabilities of aged
individuals. Our two polymeric nanovaccine platforms, polyanhydride nanoparticles and pentablock copolymer
micelles, have been shown to increase antibody titers, improve cell-mediated immunity, and prolong antigen
delivery resulting in a protective immune response with reduced viral load upon delivery of recombinant
hemagglutinin and nucleoprotein in an IAV challenge model. Compelling preliminary data demonstrates that
these formulations differentially alter dendritic cell (DC) metabolic profile compared to traditional adjuvants. Aim
1 will identify how nanovaccine biomaterials and adjuvants that promote DC metabolic health augment the
immune response in aged mice. Different vaccine formulations will compare adjuvants that produce high
glycolytic responses with formulations that retain some oxidative phosphorylation and spare respiratory
capacity to optimize DC function. In the second aim, we will optimize the nanovaccine formulation(s) that
enhance B cell activation in aged mice and peripheral blood B cells from aged humans. Additionally, we will
identify mechanisms by which our nanovaccine improves T follicular helper responses and the induction of
protective immunity on an aging background. Traditional inactivated IAV vaccine will be used as a control so as
to identify the formulation providing superior protection than the current vaccine. In Aim 3, we will determine
how nanovaccine-induced metabolically-optimized DC-T cell priming contributes to T cell memory and
heterologous protection against IAV in aged mice. Measures of viral load, serum antibody, and lung T cell
responses will be evaluated in homologous and heterosubtypic IAV challenges in aged mice. The long-term
goal of this research is to define the mechanisms responsible for induction of protective immune responses in
aging populations, thus facilitating the rational design of improved vaccines for this underserved population.

Public health relevance
PROJECT NARRATIVE Age-related impairments of immune responsiveness result in reduced efficacy of influenza vaccination in older adults. The overall objective of this project is to develop an efficacious influenza nanovaccine for older populations, and to understand the mechanisms by which rational selection of biomaterials and co-adjuvants in vaccines can enhance immune capabilities of aged individuals.